Retinoic acid synthesis induced by noncoding dsRNA controls Regeneration

Project Summary Abstract
The long term objective of the proposed research is to learn what controls whether injuries heal with
scarring/fibrosis versus full regeneration of lost structures. The human health burden of fibrosis and scarring is
enormous and affects every tissue from heart (lost heart function after a myocardial infarction) to lung
(idiopathic lung fibrosis). Enhancing regeneration could prevent for example the almost universal recurrence of
chronic wounds in the exact location where they previously appeared. We use the Wound Induced Hair
Neogenesis (WIHN) model system where in the center of excisional wounds in mice a variable amount of
regeneration occurs and de novo hair follicles form in a recapitulation of embryogenesis. The goal of this grant
is to understand the factors which control the frequency of regeneration. We will directly test the mechanism
and the ability for candidate molecules which enhance regeneration in mice and in human subjects. The results
of this grant promise to help define new treatments and diagnostics to enhance regeneration and wound
healing.

Public health relevance
Project Narrative Our body’s response to a wound is often inadequate; instead of full regeneration of our injured tissue, we heal with scars and fibrosis. These scars do not function as the previous tissue did, which explains why for example most chronic wounds recur in the exact spot they first appeared. The relevance of the present studies is to try to understand the factors which control regeneration versus scarring; we wish to eventually test these compounds in human subjects to try to demonstrate regeneration.